Mechanisms and Consequences of Nucleic Acid Sensing in ErythroidProgenitors

PROJECT SUMMARY
This proposed research intends to elucidate the mechanisms and consequences of nucleic acid-sensing in
human erythroid progenitors and, ultimately, the outcomes of innate immune activation on erythroid cell biology
and function. Erythroid cells are typically considered inert oxygen transporters, and thus their potential
contribution to host immunity has been largely ignored. While erythropoiesis typically occurs in the bone
marrow of healthy adults, immature, nucleated erythroid progenitors and precursors escape sequestration and
circulate during normal fetal development and in response to critical illness. Recent findings challenge the
current paradigm that erythroid cells are immunologically inactive, and instead suggest that circulating
erythroid progenitors are immunomodulatory. However, there is limited knowledge of underlying mechanisms,
leaving a critical gap in our understanding of innate immunity and erythroid cell biology. Preliminary research
from the PI and her lab suggests that human erythroid progenitors sense and respond to viral mimetics via
activation of nucleic acid-sensing pattern recognition receptors and downstream signaling pathways. This
proposed research will test the hypothesis that erythroid progenitors possess innate antiviral immune functions,
and that activation of immune signaling pathways in erythroid progenitors impacts differentiation, maturation,
and function of mature erythroid cells. This hypothesis will be tested through systematic investigation of both
DNA-sensing (Aim 1) and RNA-sensing (Aim 2) pathways utilized by erythroid progenitors to contribute to host
antiviral defense. Further, these studies propose to characterize the downstream consequences of nucleic acid
sensing on erythroid cell function and development (Aim 3). The long-term goal of this research is to gain a
deeper understanding of the interplay between immunity, inflammation, and red blood cell biology. All of the
proposed experiments will be conducted by undergraduate students under the close mentorship and
supervision of the PI, enabling students to gain valuable hands-on experience and begin building a long-term
career in biomedical research.

Public health relevance
PROJECT NARRATIVE Transcriptionally active nucleated erythroid progenitors circulate in developing fetuses and severely ill adults, yet their contribution to immunity and host defense in these vulnerable populations has been overlooked. The proposed studies will provide valuable insight into the innate immune functions of human erythroid progenitor cells, as well as the long-term consequences of immune activation on erythroid cell biology and function. Overall, this proposed research holds the potential to expand our knowledge of red blood cell biology in the context of immune activity, which could lead to new therapeutic interventions for immune dysregulation in critically ill individuals and may improve our ability to diagnose and treat neonatal disease.